Development of Culturally Tailored Content for Smoking Cessation and HIV Care Improvement among Latinx Adults: A Pilot Study

PROJECT SUMMARY/ABSTRACT
Racial/ethnic minority groups are disproportionately affected by HIV, people with HIV/AIDS (PWH) are at increased
risk for smoking, and smoking presents a major health hazard to individuals with HIV and affects disease
management. For example, cigarette smoking is a leading risk factor for HIV-related and non-HIV-related morbidity
and mortality among PWH, even among those taking antiretroviral (ART) medications, and contributes to more life-
years lost than HIV-related complications among those effectively treated with ART. Latinx/Hispanic adults (hereafter
referred to as Latinx) with HIV who smoke are at high-risk for smoking-related health disparities and poorer response
to HIV treatment. Latinx smokers with HIV experience more difficulty quitting, are less likely to use pharmacological
support for smoking cessation, and are less likely to be a former smoker than non-Latinx White smokers with HIV.
Challenges managing somatic perturbation related to stigma and discrimination experienced by Latinx smokers with
HIV may contribute to quit difficulty and subsequently impact HIV disease management. Anxiety sensitivity (AS) is a
core affective vulnerability factor implicated in internal distress that has emerged as a leading mechanistic target for
behavioral health interventions, is related to smoking behavior and cessation, and has been implicated in HIV
symptom distress severity. AS reduction improves anxiety, depression, and enhances quality of life among PWH,
which can improve HIV-specific outcomes including ART adherence and treatment engagement. Smoking cessation
treatment that specifically targets AS leads to better smoking outcomes among PWH. Yet, no work has leveraged the
potential to target AS reduction to improve smoking cessation and HIV care outcomes in the context of an accessible,
tailored intervention for Latinx smokers with HIV. The goal of the current proposal is to develop culturally tailored
content for AS reduction, smoking cessation, and HIV disease management among three unique groups of Latinx
smokers with HIV: Mexican Americans, Central Americans, and South Americans. To achieve this objective, our team
will adapt our existing materials for AS reduction, smoking cessation, and HIV care engagement to incorporate unique
cultural aspects for Mexican American smokers with HIV and then pilot these materials among 40 Mexican American
smokers with HIV. Intervention content will then be refined and adapted to the unique cultural considerations for two
additional subgroups of the Latinx population: (1) Central Americans and (2) South Americans, and subsequently
piloted on Central Americans (N = 20) and South Americans (N = 20). Following completion of the proposed study, we
will have developed culturally tailored content to improve smoking cessation and HIV care engagement/management
among three unique subpopulations of the larger Latinx population that will have been informed and vetted by a strong
team of researchers, community members who treat the target population, and the target population. Once refined,
these materials will be ready for integration and testing within a smartphone-based application targeting improved
outcomes. The proposed project is centrally relevant to public health because it can help guide the development of
novel culturally tailored smoking cessation interventions and HIV care among Latinx smokers with HIV.

Public health relevance
PROJECT NARRATIVE Latinx/Hispanic (hereafter referred to as Latinx) persons who smoke cigarettes and are HIV+ in the United States are a health disparities group for poorer smoking and HIV outcomes, which poses a major public health concern. The proposed research aims to develop culturally tailored intervention content and intervention materials for three unique groups of Latinx smokers with HIV (i.e., Mexican Americans, Central Americans, and South Americans) to improve rates of cessation and HIV care engagement. Following this research, we will be well positioned to integrate the developed and refined materials into a smartphone-based application and subsequently test the efficacy of the application to improve smoking cessation and HIV care management among this health disparities group.